Molecular and Translational Studies in Hematologic Disorders

This application for an NHLBI R35 Outstanding Investigator Award is to continue R35-funded studies on mech-
anism of disease in von Willebrand Disease (VWD) and sickle cell disease (SCD). Both diseases involve von
Willebrand factor (VWF). In VWD, VWF has a starring role; in SCD, it is one of many actors involved in a very
complex pathophysiology. In types 2A and 2B VWD, caused by dysfunctional VWF that results in loss of the
largest and hemostatically most active multimers, excessive ADAMTS13-mediated cleavage occurs and the
number of small, cleaved VWF fragments is high. In the proposed studies, we will investigate the impact of
these fragments on hemostasis, as we have evidence that the small fragments have functions not found in large
multimers, one fragment interfering with hemostasis by blocking platelet binding and VWF self-association, and
the other competitively inhibiting ADAMTS13. In our SCD studies, we have substantial evidence that oxidation-
induced changes to lipids in the sickle erythrocyte membrane and plasma lipoproteins play major roles in the
pathophysiology of vasoocclusion. Oxidation converts the sickle erythrocyte to an agonist capable of activating
platelets, leukocytes, and endothelial cells, probably by generating bioactive oxidized lipids such as platelet-
activating factor and lysophospholipids. Oxidation of usually protective plasma high-density lipoprotein makes
it proinflammatory. In this application, we propose to use a wide variety of in vitro and in vivo approaches to
address these questions. For the VWD studies, we will study normal blood and patient blood, recombinant pro-
teins, and use AI-assisted structure and docking. Experimentally, we will use a variety of microfluidic techniques
and observe the in vivo effects of VWF cleavage fragments using intravital microscopy. For the SCD studies, we
will continue to refine mass spectrometry techniques to identify candidate oxidized phospholipids in erythro-
cytes and lipoproteins and study the lipidomes of a variety of patients to understand the extent of variability.
Finally, we will evaluate candidate lipids for their ability to induce vasoocclusion and test interventions to re-
duce the negative impact of in vivo oxidation. We expect these studies to increase our understanding of the
mechanisms of disease in the two disorders, to provide new biomarkers to study the diseases, and to improve
the treatment in afflicted patients, both by increasing understanding and by providing new therapeutic leads.

Public health relevance
Work proposed here will continue work to elucidate mechanisms of disease in von Willebrand disease (VWD) and sickle cell disease (SCD). In VWD, we will address the hypothesis that ADAMTS13 cleavage fragment of VWF interfere with the function of normal VWF and that this plays a role in type 2 VWD. In SCD, we will explore the role of lipoproteins and oxidized phospholipids in vaso-occlusive crisis.